Mechanism and optimization of CBD-mediated analgesic effects (Admin Supplement)

Project Summary
The pathogenesis of Alzheimer’s Disease (AD) is a complex process involving multiple steps and players, which
poses major challenges for mechanistic understanding and therapeutic development. The primary pathologic
criteria for AD diagnosis include extracellular deposition of β-amyloid plaques and intracellular accumulation of
tau neurofibrillary tangles. Clinical imaging studies suggest that the spatiotemporal spread of tau pathology
typically starts from the entorhinal cortex and correlates closely with cognitive impairment. Furthermore,
mechanistic research in animal models suggest that tau release and uptake across synaptically connected
neurons are regulated by both neuronal and microglia activity. Due to the paucity of disease-modifying agents
for AD, there is a critical need to test potential therapeutic strategies that may halt the spread of tau pathology
by modulating neural and microglia activity. Cannabidiol (CBD) is the main non-psychoactive cannabinoid in
Cannabis sativa with a range of reported pharmacological effects, including anti-inflammatory, anti-epileptic, and
analgesic properties. The parent project of this research supplement is entitled “Mechanism and optimization of
CBD-mediated analgesic effects”, with major goals to identify the neural mechanisms involved in the in vivo
actions of CBD in order to optimize its analgesic effects. Our research from the parent project has provided
evidence that CBD treatment modulates both neuronal and microglial activity in the brain with good safety profile.
The overall objective of this AD-focused supplement is to investigate the mechanistic effects of CBD on
the spread of tau pathology in mouse models. We hypothesize that CBD treatment can suppress excessive
neural and microglial activity thereby reducing the spread of tau pathology in brain circuits. To explore this
hypothesis, we will use a recently established, efficient viral vector model to study the propagation of human tau
protein in mouse brain circuits. Specifically, we will determine if CBD suppresses activity-dependent propagation
of tau protein from the entorhinal cortex, and if CBD alters microglia reactivity states to limit the spread of tau
pathology. The outcomes of this research will inform potential development of cannabinoid-based therapies to
reduce tau spreading in AD via suppression of excessive microglial and neuronal activity.

Public health relevance
Project Narrative We propose to investigate the mechanistic effects of cannabidiol on the spread of tau pathology in mouse models. This research will inform potential development of cannabinoid-based therapies to reduce tau spreading in Alzheimer’s disease via suppression of excessive microglial and neuronal activity.